TECHNICAL AND LOGISTICAL SUPPORT FOR CANCER SURVEILLANCE - CORE EXTENSION

The primary objective of this project is for the provision of logistical support to facilitate collaborations for projects in cancer surveillance supported by NCI via a web-based knowledge management system. This system shall include the capability to create and maintain email lists and contact information; post and track manuscripts and post data resources; manage shared files, specifications, and templated output spreadsheets; facilitate the changing affiliations of collaborators; and add new collaborators. The contractor shall have capability in maintaining a knowledge management system, developing and maintaining interactive websites, and interacting with researchers in cancer surveillance to assist them in communicating and meeting, and to provide portals to document their work and make it more accessible to the general research community.